Center for Genetic Studies of Drug Abuse in Outbred Rats

Project Summary/Abstract (Core A: Administrative Core)
The Administrative Core will facilitate coordination amongst all other cores, research projects and affiliated
grants. Dr. Palmer is the Center Director and PI of this Core; he will be assisted by Dr. Oksana Polesskaya,
who has served as the Scientific Director of this core since January 2015. We have identified six key Aims for
the Administrative Core: 1) Promote interactions among center PIs, 2) Maintain the center’s website and
database, 3) Maintain and communicate with the External Advisory Board (EAB), 4) Promote education and
outreach 5) Resolve conflicts and develop a succession plan, and 6) Provide general administrative support.
The fourth Aim focuses on education and outreach, which has been a major priority of the Administrative
Core during the initial funding period. We will continue to provide training for both high school and
undergraduate students by supporting a summer research program that places them into one of the center’s
laboratories. We will extend on our past success in attracting members of underrepresented minorities,
persons from disadvantaged backgrounds and persons with disabilities. We will also continue to aid in the
developing careers of technicians, graduate students, postdocs and junior faculty involved in this center, in part
through the use of individual development plans and research performance progress reports. Finally, the
Administrative Core will be responsible for organizing public outreach activities that will draw on the diverse
neighborhoods around the University of California San Diego (UCSD), the University of Michigan (UofM), the
University of Colorado Denver (UDenver), the University at Buffalo (UB), University of Tennessee Health
Sciences Center (UTHSC), and Wake Forest University School of Medicine (WFUSM).